Administration

ABSTRACT: Administrative Core
The overall goal of the Administrative Core is to provide scientific leadership and a framework for support
services to ensure accomplishment of the research and educational missions of the Center. The Aims of this
Core are to provide leadership and management for the Center in four broad areas: 1) Research; 2)
Training; 3) Dissemination; and 4) Collaborations. To achieve these aims, the Administrative Core functions
in the planning, evaluation, and oversight of scientific activities, the provision of sound fiscal management and
the coordination of research projects, scientific cores, and training activities. It assures effective clerical,
information technology (IT) and library services, promotes career enhancement opportunities, and provides
opportunities and resources for participation in the dissemination and translation of findings. With the Center
Management Group, the Core develops collaboration with researchers at national and international levels. It
fosters an intellectually lively, multi-disciplinary climate of discovery, one stimulated by enrichment activities from
visiting experts who help us keep connected to advances elsewhere. This proposal for the continuation of the
Alcohol Research Group's (ARG) National Alcohol Research Center in the Epidemiology of Alcohol Problems:
Alcohol-related Disparities will involve continued leadership from Dr. William C. Kerr, who has successfully led
the Center since 2016. Principal Investigator and Scientific Director Kerr will be assisted by Dr. Nina Mulia who
will be the Associate Director in the new Center, with responsibilities for greater coordination of disparities
research across Center components and support for disparities-focused dissemination and collaboration. Dr.
Kerr will assume responsibilities for training in conjunction with leadership of the affiliated NIAAA T32 Training
Grant, and including research career mentoring and leadership of the Center's enrichment program. PI Kerr and
Dr. Mulia are joined in the Center Management Group by Component Directors Dr. Priscilla Martinez, Dr. Camillia
Lui, Dr. Meenakshi Subbaraman, Dr. Won Kim Cook, and former Center Director Dr. Thomas Greenfield and
former Center Associate Director Dr. Cheryl Cherpitel. The Management Group will ensure that Center
components and the ARG's independent grants are well integrated and interact productively, marshalling
resources and seizing scientific opportunities where they arise. The Management Group serves as a steering
committee for the Center, meeting monthly to provide regular updates on Cores and Projects, oversight of
research quality, and monitoring of the timely execution of proposed activities and the achievement of Aims.